Defining the determinants of response and resistance to therapy for Richter's Syndrome

Abstract
Richter's Syndrome (RS) arises from chronic lymphocytic leukemia (CLL) and has long been acknowledged as
presenting a bleak clinical outlook for CLL patients. New treatment combinations, however, incorporating novel
agents suggest the feasibility of achieving deeper and longer-lasting remissions in patients with RS. These
include treatment with immune checkpoint blockade (ICB; -PD1 therapy) together with ibrutinib, and
combination of the BCL2 inhibitor venetoclax with chemotherapy. These experiences provide encouraging
developments for an entity hitherto considered a death sentence for CLL patients. Despite these promising
therapeutic developments, little information is available regarding the determinants of clinical response to these
therapies. The recent increase in clinical investigation of novel therapeutic agents for RS now provides an
opportunity to more consistently collect biospecimens. Moreover, the recent availability of novel sequencing
capabilities, analytic tools and animal models (generated by our efforts over this past funding period) now enable
us to maximally extract information about the diverse molecular and phenotypic features of RS from primary
patient material. We hypothesize that therapeutic response and resistance to RS therapy are shaped by
both tumor-intrinsic and -extrinsic features, and that these features underlie the differential sensitivity
to novel agents between RS and CLL. Herein, we will undertake in-depth analysis of specimens collected on
therapeutic trials, focusing on longitudinal analyses of both RS specimens and their microenvironment, and also
functional validation of these findings in a novel animal model. These studies are supported by strong interactions
with Projects 1 and 3, and each of the individual Cores. Our aims are thus to: (i) Define the RS-intrinsic features
that govern responses to RS therapies. We will evaluate the molecular characteristics of serially collected RS
specimens from patients treated with: (i) BCL2 inhibitor-based and (ii) ICB-based therapy, and link these
attributes with clinical features to identify markers/pathways predictive of response or resistance to therapy. (ii)
Delineate the key components of the RS immune microenvironment impacting therapeutic response. New
immunogenomic approaches enable us to gain fresh mechanistic insights directly from analyzing patient
samples. We will perform scRNA-seq profiling of marrow or lymph node-infiltrating immune cells from RS
responders and nonresponders per therapy (enrolled on the aforementioned trials) to systematically characterize
the composition and functional state of cellular populations participating in response or resistance to novel RS
therapeutic combinations. Finally, we will: (iii) Model differential therapeutic sensitivity of RS to -PD1 therapy
compared to CLL. Using novel genetically engineered mouse models that reflect CLL or RS disease, we will
perform in vivo treatment studies and functional/phenotypic analyses of immune cells to determine the genetic
and microenvironmental basis of RS response to ICB compared to CLL.

Public health relevance
Narrative A serious complication of chronic lymphocytic leukemia (CLL) is the transformation from this relatively slow- growing malignancy to a highly aggressive lymphoma-like disease, called Richter's Syndrome (RS). Since newer therapies for RS are beginning to show promise in the treatment of this deadly entity, we propose to perform a parallel analysis of evolution of both RS cells and their surrounding immune cells over time and in relationship to these novel therapeutic strategies. By employing a suite of cutting-edge experimental tools, new analytic pipelines and new animal models, we will perform an in-depth tumor cell and immune profile analyses of samples collected from a unique portfolio of innovative investigator-initiated clinical trials for which clinical response data will be linked; and we will investigate the idea that tumor cells shape and are shaped by their immune microenvironment.